IMPULSIVITY AND PATHOLOGIC GAMBLING

This study was conducted to investigate biological substrates of pathological gambling. We found indices of increased central nervous system noradrenergic activity. Also, depressed gamblers showed evidence of abnormal glucose homeostasis.